Understanding interplay between the Hsp70 chaperone code and Cyclin D1/Cln3

Project Summary
Hsp70 is vital molecular chaperone that folds a large proportion of the proteome. Research has primarily focused
on how Hsp70 function specificity arises through regulation of a) expression of Hsp70, b) isoform differences in
the Hsp70 protein family and c) the variety of co-chaperone proteins that bind to the Hsp70 molecule. Despite
the identification of several phosphorylation sites on both yeast and mammalian Hsp70 through global proteomic
screens, the biological function of most of these sites remains unknown.
All organisms require correct coordination of the cell cycle to grow and proliferate. Uncontrolled cell cycle
progression can result in either cell death or metastasis. Progression of the cell from G1 to G2 requires the
activity of cyclin-dependent kinase (CDK) CDK4. The critical activity of CDK4 is regulated by binding to cyclin
proteins such as Cyclin D1, which rises and falls in abundance periodically through the cell cycle. As such,
altered Cyclin D1 activity (achieved through increased transcription or stability) is often correlated with
tumorigenesis. Any strategy that lowers Cyclin D1 activity in cells may form the basis of novel anticancer
therapies.
Our studies have determined that phosphorylation of a single site on Hsp70 regulates chaperone function by
altering both co-chaperone and client protein interactions. In particular, we have shown that increased Hsp70
T38 phosphorylation promotes Cyclin D1 destruction.
In this proposal, we will investigate the role of other Hsp70 PTMs (the chaperone code) on Cyclin D1 levels
in yeast and mammalian cells using the chaperone code array. We propose to use cross-linking mass
spectrometry to fully characterize the Hsp70-Cyclin D1/Cln3 interaction, including binding surfaces and PTMs
involved. The scope of this work has broad implications for a variety of diseases associated with both the cell
cycle and molecular chaperone function, including many types of cancer and neurodegenerative illnesses.

Public health relevance
Project Narrative This study will allow us to understand how modifications on an major regulatory protein (Hsp70) are controlled affect the stability of important proteins that bind to Hsp70, particularly those associated with cell growth and division. The scope of this work has broad implications for a variety of diseases associated with both the cell cycle and molecular chaperone function, including many types of cancer.